A mechanistic understanding of treatment-related outcomes of sleep disordered breathing using functional near infrared spectroscopy

PROJECT SUMMARY
Sleep disordered breathing (SDB), characterized by snoring and sleep disruption, affects one in ten children.
Adverse outcomes of SDB such as problem behaviors, sleepiness, and lower quality of life contribute to poor
classroom performance and are thought to be related to structural and functional alterations within the prefrontal
cortex (PFC) of the brain. All clinical societies therefore support universal screening for SDB in children and its
treatment by removal of tonsils and adenoids (adenotonsillectomy or ‘AT’), a surgery performed in 500,000 chil-
dren annually in the United States alone. However, some children also experience spontaneous resolution of
SDB and therefore watchful waiting is also an acceptable treatment option for these children. Currently there are
no uniformly accepted criteria for children likely to benefit from AT as opposed to watchful waiting. Polysomnog-
raphy is currently used for stratification of SDB severity. However, polysomnographic parameters neither corre-
late with behavior, cognition, or quality of life nor the outcomes of AT in children with SDB. Therefore, two major
gaps in knowledge exist, which include the lack of (i) understanding the mechanism by which AT impacts SDB
outcomes, and (ii) a predictive model for selection of children likely to benefit from AT. Addressing these gaps
could improve patient selection, reduce harm, and increase parental satisfaction related to one of the most com-
mon pediatric surgical procedures.
We have shown that the relationship between SDB and children’s behavior is mediated by structural alterations
within or close to the PFC. Using functional near-infrared spectroscopy (fNIRS), we have further demonstrated
that regional brain activation within the prefrontal cortex (PFC) correlates with behavioral measures in children
with SDB. Using a range of data science techniques, we have additionally shown that polysomnographic param-
eters do not predict SDB or AT outcomes. Here we propose the use of a novel biomarker for functional activation
of the PFC using fNIRS and baseline patient characteristics to predict outcomes of children undergoing SDB
treatment. In 200 children undergoing management of SDB by early AT or a strategy of watchful waiting at two
large and diverse clinical practices, our specific aims include: Aim 1) To determine the extent to which cognitive
outcomes of AT are mediated by PFC activation, Aim 2) To determine the extent to which parent-reported out-
comes of AT are mediated by PFC activation, and Aim 3) To develop a predictive model for SDB treatment
outcomes using demographic, anthropometric, polysomnographic, and fNIRS variables. Using a multidisciplinary
approach with world-class expertise in data science approaches, this proposal seeks to address gaps in our
mechanistic understanding of AT outcomes and establish an objective, child-friendly, and cost-effective ap-
proach for identification of surgical candidates.

Public health relevance
NARRATIVE Over half a million children undergo removal of tonsils and adenoids (‘adenotonsillectomy’ or AT) every year, primarily for the treatment of sleep disordered breathing (SDB). Two serious issues impact AT candidacy assessments in children, which include the lack of (i) mechanistic understanding of how AT impacts SDB outcomes, (ii) and objective indicators for the magnitude of benefit from AT. By addressing these gaps using a novel biomarker of brain activation, we aim to reduce unnecessary surgeries, increase objectivity, improve disparities, and aid shared decision making related to the most common surgery performed in children under 15 years of age.